Adapting and Pilot Testing a Multi-Level, Peer-Led HIV Prevention and Stigma Reduction Intervention for Adolescents in Western Kenya

Project Summary/Abstract
Adolescents are particularly vulnerable to HIV and AIDS globally, including Kenya. In western Kenya, youth are
disproportionately affected by HIV due to poverty and lack of education, which can lead to risky sexual behav-
iors. Stigma is one of the primary barriers to HIV prevention among youth in Kenya. Our prior research in west-
ern Kenya demonstrates that HIV-related stigma among youth is associated with lower odds of condom use
and HIV testing, and stigma associated with sexual and reproductive health (SRH) also impacts HIV outcomes.
Further, we found that social capital is protective against stigma, and youth are comfortable talking about sex
and HIV in trusted groups of peers. However, youth lack skills and confidence to talk to adults and partners
about HIV. Therefore, there is a critical need to strengthen young people’s resilience by improving communica-
tion and building social capital, which will reduce HIV- and SRH-related stigma and increase HIV prevention in
western Kenya. We will use implementation science methods to adapt a theory-based, evidence-informed in-
tervention, Sisters Saving Sisters (SSS), in 4 important ways: (1) develop a version for boys (Brothers Saving
Brothers [BSB]), (2) develop content on HIV- and SRH-related stigma, (3) add content PrEP and HIV testing;
and (4) create content to improve communication between youth and their parents/caregivers. We hypothesize
that our adapted intervention (SSS and BSB) will reduce HIV- and SRH-related stigma and increase HIV pre-
ventive behaviors among youth in western Kenya. This study will take place in Kakamega County and will build
upon an established partnership between the University of Iowa and Africa Community Leadership and Devel-
opment to address the following specific aims: (1) Adapt SSS to reflect the experiences and perspectives of
youth (ages 15-18) in western Kenya; (2) Determine the preliminary effectiveness of the adapted SSS and
BSB intervention; and (3) Evaluate the feasibility, appropriateness, and acceptability of the adapted SSS and
BSB intervention. For Aim 1, we will use the ADAPT-ITT framework to adapt and contextualize SSS by using
theater testing and focus group discussions (FGDs) with our Youth Action Team (YAT) and Community Leader-
ship Team (CLT). For Aim 2, we will implement a pilot randomized control trial by randomly assigning 3 villages
each to the intervention and control. In each intervention village, separate groups of girls and boys (n=96) will
receive the intervention over 3 weeks. In the control villages, youth (n=96) will receive the standard of care for
HIV prevention and SRH. We will assess outcomes before the intervention, and at 3- and 6-months post-inter-
vention. Primary outcomes are abstinence, condom use, PrEP use, and HIV testing; secondary outcomes in-
clude behavioral intentions and HIV- and SRH-related stigma. For Aim 3, we will use an implementation sci-
ence approach to assess acceptability, appropriateness, and feasibility through short surveys and FGDs with
participants, parents/caregivers, peer educators, and YAT/CLT members. At the end of this project, we expect
to have 2 curricula that will set the stage for a rigorous hybrid effectiveness-implementation study in Kenya.

Public health relevance
Project Narrative Stigma associated with HIV and sexual and reproductive health (SRH) is one of the primary barriers to HIV prevention, and has contributed to a high prevalence of HIV among adolescents in western Kenya. To reduce HIV- and SRH-related stigma and improve HIV preventive behaviors, our prior research demonstrates there is a need to strengthen young people’s resilience by building social connections and improve communication with adults and peers. This study will adapt a theory-based, evidence-informed, and peer-led intervention (Sisters Saving Sisters and Brothers Saving Brothers), to reduce stigma and increase HIV prevention among youth (ages 15-18 years) at high risk of HIV in western Kenya.